GLOMERULUS IN CHRONIC RENAL FAILURE--IMAGE ANALYSIS

In chronic renal disease undamaged nephrons become responsible for maintaining kidney function; yet this function may continue to deteriorate even in the absence of activity of the primary kidney disease. Subtotal renal ablation, especially when combined with an unrestricted protein diet, is most effective in reproducing this state of affairs in the experimental animal. Apparently hemodynamic changes, at first compensatory, lead to increases in glomerular capillary pressures, flows, and filtration which become counterproductive, causing glomerular hypertrophy and ultimately sclerosis. It has also been shown by model building, measurement, and network analysis that the hemodynamic response to renal ablation on high protein intake may include, in its later stages, a functional loss in filtration surface caused by shunting of glomerular capillary blood flow. This finding, however, is currently based on the study of a single glomerulus. It has been suggested, moreover, that postprandial changes in glomerular blood flow and filtration rate may be more conspicuous in superficial cortical (SC) glomeruli than in juxtamedullary (JM) glomeruli. Since such hemodynamically mediated changes have been implicated in the pathogenesis of glomerular injury precipitated by renal ablation in the Munich Wistar (MW) rat, it is not unlikely that the rate of progression of glomerular injury may differ in SC and in JM glomeruli. It has also been confirmed that morphometric differences exist between SC and JM glomeruli in the normal MW rat. Accordingly, the research plan includes a two-fold study of the responses of SC and JM glomeruli to subtotal renal ablation in the presence of unrestricted protein intake: (i) A network-analytic study of the later hemodynamic responses of several glomeruli facilitated by the use of computer image analysis for the study of three-dimensional glomerular structure; and (ii) A stereologic comparison of the parameters of glomerular hypertrophy for SC and JM glomeruli.